URIL tags for intracellular RNA tracking and RNP proximity labeling

PROJECT SUMMARY / ABSTRACT
If a facile method to site-selectively install prosthetic groups at internal sites in genetically-encoded RNA were
available, then it would be possible to modify RNAs and ribonucleoprotein complexes (RNPs) in native
structural and intracellular context, thus elevating studies on RNA folding, trafficking, lifetime, interactomes and
regulatory pathways. The objective of this application is to test the extent to which compact U-rich internal loop
(URIL) sites can be used as a general targeting motif in structured RNAs. If it were possible to selectively
target the URIL motif with chemical probes, then juxtaposition of the URIL site with protein binding RNA motifs
would enable tracking and chemical modification of ribonucleoprotein complexes (RNPs). This would enable
elucidation of motif-specific RNA location and interactome by fluorogenic and proximity (biotin) labeling of URIL
RNPs; such unbiased motif-centered interactome readout is not possible with existing methods. We
hypothesize that appropriately modified, URIL-targeting bifacial peptide nucleic acids (bPNAs) could enable
intracellular fluorogenic URIL (FLURIL) RNA tracking and proximity labeling of URIL (PLURIL) RNPs,
respectively. Our proposed plan begins with the synthesis of bPNA probes, followed by rigorous in vitro and
intracellular evaluation, optimization and validation with existing tools and known interactome partners. FLURIL
RNP tagging will be benchmarked against MS2-labeling, the gold standard in RNA tracking. PLURIL tagging
will be tested by its efficacy in identification of known RNPs. Further, we will test the extent to which URIL tags
can be used to probe disease-relevant RNP biology in the intracellular context of amyotrophic lateral sclerosis
(ALS), using patient-derived cells. Investigation of ALS pathology is a highly active area, with attention focused
on two major forms: C9-ALS and Fus-linked ALS. While C9-ALS represents a majority of ALS cases,
Fus-linked ALS is most commonly found in juvenile, aggressive early-onset cases; notably, the pathological
mechanisms of these two forms appear to be distinct. Dysregulated RNP biology centered on C9orf72 RNA
(C9-ALS) and U1snRNA (Fus-linked ALS) identifies these transcripts as prime substrates for URIL tag probes.
The rigor in the prior research lies in the substantive preliminary and published data supporting intracellular
fluorogenic and proximity labeling of URIL-RNPs. These data form a strong scientific premise for the impactful
and unique application of motif-specific URIL-tagging as a broadly enabling discovery tool in ALS pathology
and other RNP-centered diseases.

Public health relevance
PROJECT NARRATIVE Dysregulated RNA biology figures prominently in many neurodegenerative diseases for which there are currently poor treatment options, including amyotrophic lateral sclerosis (ALS). The proposed research is significant because it will contribute a set of transformative tools for study of RNA-governed biology in ALS and related neurodegenerative diseases. If successful, our approach would open new potential therapeutic and diagnostic avenues for treating neurodegenerative diseases such as ALS.